Host evolution in the wake of contemporary outbreaks of disease

HOST EVOLUTION IN THE WAKE OF CONTEMPORARY OUTBREAKS OF DISEASE
Project Summary/Abstract
In the wake of the spillover or introduction of a novel parasite or pathogen into a naïve host population,
attention focuses on the resulting host morbidity and mortality. However, emerging disease has much
broader effects on host populations, including demographic shifts, life history changes, and genetic and
epigenetic evolution. These extended effects have shaped human evolution and remain relevant in an
era of biodiversity loss and increasing zoonotic disease risk. Nevertheless, studying the evolutionary
consequences of disease remains challenging because historical disease events leave diffuse and
complex genomic signatures and because attributing changes in the host population to parasites can be
difficult without adequate replication and controls. The investigating team works in the Galapagos
Islands, an iconic natural laboratory, to study the real-time evolution of hosts to emerging disease. Over
the next five years, the team will leverage the natural experiments created by two separate parasite
introductions that occurred ~125 years ago and ~25 years ago to study changes in avian host populations
in response to these novel challenges. The Galapagos songbird (passerine) community is dominated by
two endemic radiations: Darwin’s finches and Galapagos mockingbirds. The species within each of these
groups provide the replication to test hypotheses about how host defenses against disease arise and
spread, and to determine how repeatable co-evolution is between hosts and novel parasites. Three
fundamental questions guide the overall focus on how hosts change in the wake of emerging disease: 1)
How do population size and genetic diversity govern adaptation to a novel virus? Variation in host
population size and parasite pressure among Galapagos islands will help identify how demography and
diversity shape the response to hosts to novel disease. 2) What mechanisms underlie adaptation to a
novel virus? The team’s existing work uniquely prepares them to study to what extent regulatory and
epigenetic changes drive host adaptation to novel pathogens and how routes to adaptation may vary
among host species. 3) How do hosts evolve in response to a novel parasite? Contemporary host
genomes will be compared to host genomes from before the parasite introduction to identify regions
and genes under selection. With over a decade of experience working in the Galapagos Islands and
extensive local connections, the McNew Lab is uniquely prepared to conduct the ambitious experiments
in the study of host-parasite coevolution. The results will illuminate the processes that shaped human
evolution and anticipate consequences of future emerging diseases on Earth.

Public health relevance
HOST EVOLUTION IN THE WAKE OF CONTEMPORARY OUTBREAKS OF DISEASE Project Narrative Parasites and pathogens are powerful selective agents that have shaped host evolution over millennia. The McNew Lab uses a natural experiment created by the introduction of parasites and pathogens into an island ecosystem to study the evolutionary consequences of emerging disease in real time. The insights generated from the proposed work will help illuminate the processes that have shaped our evolution as well as understand contemporary drivers of biodiversity change.